External Research Resources Support and Dissemination

Project Summary
Core D supports CDHA affiliates, the scientific community, advocates for aging, policy makers, and others
interested in aging-related research and data resources generated within CDHA and by our affiliates. The Core
does this by (a) providing means to gain access and understand documentation of complex data sets and (b)
developing CDHA’s website as a source of information for CDHA affiliates, other researchers, and the public at
large.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is located in the Overall section of this proposal.